Alterations in RBC Membrane Lipids in SCD/Infection and Impact on Hemolysis

Although hemolytic anemia is the most prominent manifestation of SCD, there is a wide phenotypic variability
leading to a broad spectrum of disease severity. The molecular drivers of hemolysis in SCD are not fully
understood, leaving a gap in the overall understanding of the disease as well as in exploring targets for
therapeutics that could improve SCD pathology. Our program will characterize potential mediators of these
differential clinical presentations by focusing on SCD hematological features that differ among SCD patients and
identifying their cause. Our preliminary data leads us to hypothesize that intracellular ROS stemming from
differential mitochondrial retention in SCD patients, among other ROS sources, causes an aberrant upregulation
of key lipid desaturase enzymes that leads to an imbalance of SCD membrane phospholipids which disrupts
membrane composition and organization resulting in membrane destabilization and premature hemolysis. Upon
Babesia infection, the integrity of the SCD membrane is further impacted because of because of the substantial
lipid requirement to support parasite proliferation and associated membrane expansion, leading to hyper
hemolysis of infected SCD. Thus, we posit that some of the pathophysiology of SCD can be directly ascribed to
RBC membrane properties. We will in Aim 1, Investigate the mechanisms by which altered sickle RBC
membrane lipid composition leads to a hemolytic phenotype: by analyzing the defective lipid pathways and
resulting membrane lipidomes in SCD RBCs and elucidating the mechanisms by which these membrane
changes impact SCD RBC structure and function. Together with our AI based sickling tool, we will probe levels
of cellular ROS as well as mitochondrial ROS to determine their impact on lipid modulating enzymes as well as
SCD sickling rates and membrane rheology changes that lead to premature hemolysis. In Aim 2, we will
Investigate the mechanisms by which Babesia infection in SCD further weakens the erythrocyte
membrane by examining changes in membrane lipid composition and loss of membrane integrity via
vesiculation, lipid scavenging, ion fluxes and loss of membrane asymmetry which we hypothesize causes a more
severe sickling phenotype and increased fragility, resulting in hyper-hemolysis. Understanding the mechanisms
that govern the maintenance of the RBC lipid bilayer and the metabolic modulation of RBC membrane
remodeling in SCD, including the impact of transfusions, and defining the molecular changes in SCD membranes
upon infection, may offer novel options for limiting hemolysis in this population.

Public health relevance
The mechanisms underlying premature hemolysis and anemia in patients with sickle cell disease and upon Babesia infection remains unknown. Focusing on the alterations in the lipid membrane of sickle red blood cells, we will analyze their impact on the structure and function of the red cells and offer ways to limit red cell membrane damage and loss of red blood cell viability.